Photocatalyzed and Enantioselective Umpolung C-C Bond Forming Reactions of Carbonyls

Project Summary New methods for the formation of carbon-carbon bonds are always at the forefront of organic reaction development. Of particular interest are those that require benign reagents, are atom-economical, and have low energy input. The projects detailed herein aim to develop new umpolung carbon-carbon bond forming reactions with visible-light mediated photocatalysis. Specifically, the projects seek to generate radical species by electron transfer to ketone-containing functional groups. This reactivity will be enabled by photocatalytic electron transfer either to or from an activated carbonyl species. Two specific goals will be approached: 1) Initial work will extend preliminary experimental results that have shown that ketyl radicals can be generated by the combined activity of photocatalysts and Lewis acids to enantioselective 1,4-additions with the use of chiral Lewis acids. 2) Electron transfer from 1,3-dicarbonyls is proposed to generate electrophilic radicals for carbon-carbon bond formation with nucleophiles. A variety of carbon-carbon bond forming reactions that involve 1,3-dicarbonyl radicals are proposed, including hydro-, amido-, and dialkylation of alkenes. In total, these new catalytic processes will provide highly efficient methods for the use of visible light to construct carbon-carbon bonds in complex and biologically relevant molecular settings. The achievement of the designed umpolung reactivity of carbonyl- containing compounds by single electron reduction or oxidation would broaden the scope of reactivity for these widely available reagents. As a result, this proposal will contribute to the general toolbox of carbon-carbon bond forming reactions with new methods that are able to simultaneously build molecular complexity and adjust oxidation state. The projects are specifically tailored to be carried out by a research team composed entirely of undergraduates and is therefore broken up into discrete individual projects. This proposal would enhance the research training and outcomes of a diverse group of undergraduates pursuing careers in the biomedical sciences.

Public health relevance
Project Narrative Small organic molecules are central to the development of pharmaceutical treatments, biological probes, and many other chemical tools that impact human health. This proposal aims to develop the generation and use of ketone-derived carbon-centered radicals for the synthesis of carbon-carbon bonds that make up the structural backbone of many bioactive small molecules. Furthermore, this research would reduce waste streams by developing fully catalytic and atom-economical methods for small molecule synthesis.